University of Washington/Fred Hutch Center for AIDS Research

ABSTRACT
This is a competing renewal application for the UW/Fred Hutch CFAR, a Tier 3 CFAR in its 35th
year and one of
the original CFARs launched in 1988. Our CFAR is a multi-institutional consortium including the University of
Washington (UW), Fred Hutchinson Cancer Center (FH), Seattle Children’s Research Institute, Access to
Advanced Health Institute (AAHI), and the University of Hawai’i at Manoa (minority affiliate). Our CFAR has
grown from 75 members in 1988 to 725
in 2022,
with participation across 38 UW departments, 5 Fred Hutch
divisions, and a large network of local and global connections, including the Bill and Melinda Gates Foundation.
NIH 2021 HIV research funding to our 5 consortium institutions exceeded $
151M, a 10% increase in the past 5
years, with representation from
most NIH Institutes that co-sponsor CFAR. Our CFAR has catalyzed substantial
growth in research infrastructure, domestic and international partnerships, and impact; the return on investment
on CFAR developmental awards is 1767% and $3 million in institutional contributions for the next
5-year cycle.
For this renewal application, we conducted an 11-step strategic planning process with input from our members
and advisory committees. Key innovations include an intentional focus on EDI and community partnerships; our
new Director and co-Director; Directors of EDI and Community Engagement; restructuring Cores and SWGs to
focus on our scientific priorities:1) Discover novel insights about HIV pathogenesis with translation into practice;
2) For HIV-associated malignancies and non-communicable diseases, conduct epidemiologic, clinical and
translational research on diagnosis, prevention and treatment interventions; 3) Design and implement testing,
prevention, and treatment strategies to mitigate health disparities and to achieve 95:95:95 goals for the HIV
cascade. Our proposal is founded on 2 cross-cutting themes: 1) Foster an inclusive, collaborative research
environment rooted in anti-racist and decolonizing principles; and 2) Cultivate equitable and mutually beneficial
community partnerships that inform CFAR research priorities and facilitate implementation and impact. Our
overall Strategic Aims are to: 1) Initiate and facilitate multidisciplinary, community-engaged research
spanning basic to implementation science, with demonstrated impact on the local and global HIV epidemic,
and 2) Develop and increase the diversity of next generation investigators by providing infrastructure
and resources for innovative research and leadership opportunities. Our CFAR will have multidisciplinary
cross-connections and provide novel science and services, through 2 Translational Science Cores (Immunology,
Retrovirology & Cure; Biomarkers and Prevention of HIV-Associated Malignancies and Non-Communicable
Diseases), 3 Clinical Cores (Clinical and Comorbidity Research; Behavioral Innovations; Implementation Science),
3 cross-cutting Cores (Administrative, Developmental, and Data Sciences and Methods), and 2 Scientific
Working Groups (Substance Use, and Health Equity). Our mature CFAR is vibrant, and will leverage our scientific
expertise and resources in novel ways to foster impactful science and the next generation of research leaders.

Public health relevance
PROJECT NARRATIVE The UW/Fred Hutch Center for AIDS Research (CFAR) is a multi-institutional consortium based in Seattle which catalyzes new HIV research and develops new research leaders across the multidisciplinary spectrum of basic, clinical, epidemiologic, statistical, sociobehavioral, and implementation science expertise necessary to bend the curve of the global HIV epidemic. During 35 years of continuous funding, the UW/Fred Hutch CFAR has facilitated substantial growth in research infrastructure, domestic and international partnerships, research impact, and development of emerging HIV researchers (with a return on investment on CFAR developmental awards of 1767%) with high added value and aided by significant institutional commitment. Through our proposed eight Cores and two Scientific Working Groups, we aim to expand multidisciplinary HIV research that spans bench to bedside to populations and grow new researchers, research leaders, infrastructure, and resources to impact the global epidemic.